Polarization Metasurface Detection Device for Food Safety

Project Summary/Abstract
For farm-to-fork testing for the entire food supply chain, Nanohmics proposes to develop its metasurface-based
MetaDotTM bind-and-detect biosensor for portable, low-cost, rapid, highly sensitive multiplex screening of foodborne
pathogens. Nanohmics’ MetaDot optical reader is designed to measure pathogen binding on a custom optical
metasurface test chip coated with an array of bioreceptor regions (dots), each functionalized for direct covalent
receptor binding using aminated antibodies or DNA aptamers. MetaDot will provide easy and highly accurate
multiplex detection, identification, and quantification of foodborne pathogens. Each single-use functionalized
biosensor chip is mounted in a custom cassette for precise insertion into the MetaDot reader. When the biosensor chip
is exposed to the rinsate or solution under test, the reader probes the 36 dot regions simultaneously using polarized
monochromatic light reflected by each dot as a function of the density of local pathogen binding. Phase II will
demonstrate a simultaneous test for less than $3 for 36 dots, enough to cover the 31 major identified foodborne
pathogens. The Phase II program will develop and test the MetaDot prototype:
Research Aim 1 addresses low-cost multiplex functionalization using a microspotting robot.
Research Aim 2 develops the reader.
Research Aim 3 concentrates on reducing the cost of metasurface microfabrication.
Phase I has already demonstrated a scalable fabrication process that can reduce metasurface cost to dollars per chip.
MetaDot’s active probing architecture and transparent substrate avoids the photon-starved, low-SNR operation of
fluorescence and other detection technologies. Instead, MetaDot provides high signal-to-noise ratio (SNR) and highly
accurate and repeatable measurements. Existing pathogen test systems are often costly, non-portable, or require
operation by a laboratory technician. In contrast to commercial surface plasmon resonance (SPR) detection, the
proposed metasurface has many times more microscopic surface area, increasing overlap between pathogens and the
evanescent electric-field of the reflected light. Compared to existing SPR sensors, the MetaDot system reduces cost
and size by two to three orders of magnitude. Unlike optical techniques based on external labeling, resonance
shifting in the MetaDot metasurface operates as a reporter of the pathogen binding phenomena in a label-free fashion
and enables transduction of the capturing event directly as a shift in the polarization of the reflected light. The MetaDot
reflection probe geometry separates the optical path from the test solution, minimizing scatter and enabling extremely
low noise and high sensitivity.
The MetaDot reader is designed to use common commercial off-the-shelf (COTS) optics and electronics and will
be easy to use and inexpensive to manufacture. MetaDot can be extended to detect a wider range of pathogens for
point-of-care (PoC) applications as diverse as first-aid wound infection diagnosis, on-site dental pathogen assessment,
and screening for infectious diseases at ports of entry.

Public health relevance
Project Narrative The lack of ubiquitous, low-cost food safety screening is costly in terms of both commerce and human health. Low- cost, rapid (within minutes), high-throughput, highly sensitive testing with portability to ports of entry and food processing plants could have great value to the FDA and USDA Food Safety Inspection Service (FSIS) and the whole food industry. To address food testing challenges, Nanohmics, Inc. is developing the MetaDotTM bind-and-detect biosensor for portable, low-cost, rapid, and highly sensitive multiplex food safety screening, to provide easy and highly accurate detection, identification, and quantification of foodborne pathogens.